Intestinal mitochondrial dysfunction and the gut-brain-immune axis in models of Parkinson's Disease

PROJECT SUMMARY
Parkinson’s Disease (PD) may begin in the gastrointestinal (GI) tract. The overall goal of this research is to
identify intestinal pathogenic mechanisms in PD that may lead to the identification of gut-biomarkers for early
diagnosis as well as gut-directed therapies to halt progression of disease in the premotor phase. The proposed
research addresses the hypothesis that mitochondrial dysfunction in the intestinal epithelium causes PD via
the gut brain immune axis through two specific aims. The first aim will determine the role of mitochondrial
dysfunction in mediating the response of the intestinal epithelium to enteric neuron pathologic α-Synuclein.
This will be accomplished through measurement of inflammation and mitochondrial stress in duodenal tissue,
isolated crypts and intestinal organoids from a PD model (mice over-expressing human α-Synuclein). In
addition, these measures will be evaluated in wild type organoids treated with conditioned media from
organotypic cultures of the enteric nervous system in the same PD model. The second aim will test the
hypothesis that impaired mitophagy in the intestinal epithelium causes persistent central pathology and motor
deficits in a gut-seeding PD model. This will be accomplished through duodenal injection of α-Synuclein
preformed fibrils in mice with intestinal epithelial-specific Parkin knockout and wild type mice.
This proposed research will provide Dr. Elizabeth Videlock, a board-certified Gastroenterologist, with training in
the research skills necessary to study the gut-brain axis in PD. This technical training is a component of a
comprehensive career development plan designed to facilitate her transition to independence. Her mentorship
team is led by Nigel Maidment, Professor of Psychiatry and Biobehavioral Sciences, who has extensive
experience studying dopamine neurotransmission in rodent models of PD and a strong track record in
mentoring trainees to independence. Co-mentors will provide mentorship in assessment of the enteric nervous
system (Million Mulugeta), intestinal organoids (Martin G. Martin), and leadership skills (Lin Chang). In
addition, an advisory panel will provide mentorship for content related to the role of the gut in PD (Yvette
Taché, Michael Camilleri) and mitochondrial morphology and metabolism in epithelial cells (Leanne Jones,
Rajat Singh). The strength of the clinical and basic science programs in metabolism, neurodegenerative
disease and the gut-brain axis make UCLA the perfect institution to support this interdisciplinary proposal.

Public health relevance
PROJECT NARRATIVE Parkinson’s Disease may begin in the gut. This research will determine how damage to mitochondria in the intestine can contribute to the spread of Parkinson’s Disease pathology (α-Synuclein) from the gut to the brain. Findings from this research may lead to new ways to diagnose Parkinson’s Disease earlier, as well as new ways to treat both damage to neurons in the brain and gastrointestinal symptoms through therapies directed at the gut.